Healthcare Delivery Research Visiting Scholars Program.

The primary objective of this requirement is to recruit applicants and administer a visiting scholars program aimed at making significant progress in priority areas of healthcare delivery research. The program will support up to two scholars. The goal of this program is to advance the science of healthcare delivery research.